Molecular Mechanisms Remodeling Dynamic Landscapes in Multidomain Enzymatic Factories

Project Summary
Our laboratory is broadly dedicated to understanding the role of protein dynamics while facilitating the
engineering of nonribosomal peptide synthetases (NRPSs). Recent structure determination
advancements have highlighted that multidomain proteins are often dynamic, exhibiting distinct
functional outputs mediated by specific domain interactions. Elucidating the mechanisms underlying
how domains transition between these stable interactions remains an outstanding question that must
be answered for effectively engineering dynamic multidomain proteins like NRPSs. NRPSs utilize a
modular, multidomain architecture to covalently link simple substrates and synthesize complex
natural products, many with therapeutic properties (e.g., antibiotics like bacitracin or antitumor agents
like epothilones). Swapping domains or modules within NRPSs holds promise for developing
improved pharmaceuticals. However, their inherent dynamic nature complicates the interpretation of
mutagenesis data obtained through traditional static structures. Engineering NRPSs is thus akin to
solving a complex, multidimensional puzzle. To address this challenge, we will combine nuclear
magnetic resonance (NMR) spectroscopy and computational approaches to determine structural
ensembles that enable the prediction of how mutations affect protein functions by altering their
dynamics. Furthermore, we will initiate single-molecule studies to link these intra-domain changes to
inter-domain communication, enabling a holistic interpretation of product formation assays. Our
results will identify key residues that must be modified to alter substrate and domain recognitions and
also to maintain functional dynamics during NRPS engineering. Leveraging over 20 years of expertise
in NMR protein dynamics and large protein studies, we will collaborate with specialists in all other
relevant areas to ensure the success of this research. Our findings will pave the way for effective
NRPS engineering, facilitating the development of novel therapeutics. Additionally, our work will offer
a valuable paradigm for understanding how dynamic multidomain systems remodel domain
interactions to regulate function, a ubiquitous phenomenon across biological systems.

Public health relevance
Project Narrative The research focuses on determining how enzymatic systems synthesizing natural products with pharmaceutical applications operate through a dynamic multidomain architecture. By elucidating the connections between remote active sites in dynamic multidomain proteins, the results will guide researchers in designing mutagenesis strategies that preserve functional dynamics during protein engineering, enabling the development of multidomain proteins with customized functionalities. This research will provide a basis for developing improved therapeutics such as antibiotics, immunosuppressants, or anti-cancer agents, and a rationale for combating virulence of Y. pestis (plague), uropathogenic E. coli (urinary tract infections), V. cholera (cholera), M. tuberculosis (tuberculosis), and others.